Engineering Tregs for autoimmune diabetes therapy

SUMMARY
Type 1 diabetes (T1D) is an autoimmune disease caused by the immune mediated destruction of
insulin-producing beta cells, significantly impacting human health. Tolerance to beta cells is normally
maintained by regulatory T cells (Tregs). In T1D, Tregs stop protecting beta cells and leave them
vulnerable to immune attack. Work in T1D models has shown that therapeutic restoration of Tregs
can prevent disease progression, and clinical studies have shown the safety of this approach in
humans. Despite these successes, infusion of polyclonal Tregs has limited clinical efficacy,
representing key knowledge gaps. These challenges could be solved by creating “designer” Tregs
that are engineered for islet antigen specificity. If successful, this technology would lead to a more
personalized and effective T1D immunotherapy.
We recently developed an efficient way to generate monoclonal antibodies that recognize peptides
bound to MHC molecules. Using this approach we created a series of antibodies that are specific for
islet-reactive peptide-MHCI and peptide-MHCII complexes, called ‘TCR-mimics’, relevant for
autoimmunity in NOD mice and humans. We used these reagents as chimeric antigen receptors
(CAR) to develop Tregs so they were antigen-specific. We demonstrated these CAR Tregs were
specific and elicited suppressive functions. In preliminary studies we have shown in vivo feasibility by
preventing autoimmune diabetes in mice. Our central hypothesis is that re-directing the specificity of
Tregs can be harnessed to prevent and treat T1D. We hypothesize that engineered p:MHC CAR
Tregs will provide superior suppression relative to TCR Tregs in autoimmune diabetes.
We will test three specific aims; 1) Test efficacy of MHCI and MHCII CAR Treg-mediated
suppression in vitro and in vivo, 2) Determine the mechanisms and differential gene expression
mediating CAR Treg suppression, and 3). Evaluate synergy between CAR Tregs and anti-CD3
therapy in autoimmune diabetes. Our innovative approach, using p:MHC mAbs to generate CAR
Tregs targeting islet antigens allows us to determine if engineered antigen-specific Treg will be
optimal to prevent or reverse T1D pathogenesis. The results from this study will also determine the
mechanism(s) for suppression for these engineered Tregs. Finally we will compare MHCI- or MHCII-
restricted CAR Tregs and determine if both are required for optimal diabetes therapy either alone or
in combination with anti-CD3 therapy. We are applying our knowledge to human CAR Tregs to test in
preclinical models and are making additional CAR Tregs monthly. We strongly believe CAR Tregs are
the next T1D therapy, and the time to focus on this therapeutic option is now.

Public health relevance
PROJECT NARRATIVE In type 1 autoimmune diabetes there is a breakdown in immunological tolerance and regulatory T cells (Tregs) stop protecting beta cells, leaving them vulnerable to immune cell attack. We recently developed an approach to engineer antigen-specific Tregs by re-directing their specificity using chimeric antigen receptors targeting peptide:MHCI or peptide:MHCII complexes. The goals of this proposal are to utilize the engineered Tregs specific for islet antigen targets and reestablish immune tolerance to prevent or treat autoimmune diabetes.